Enrichment Program

The goals of the Michigan Center for Diabetes Translational Research (MCDTR) Enrichment Program continue to be to:
1. Advance research along the spectrum of diabetes T2-T4 translational research to prevent diabetes and enhance health and wellbeing of people with diabetes, with a specific emphasis on novel approaches to improve health outcomes and mitigate health differences for people with prediabetes and diabetes through education and training programs. Promote scientific exchange among investigators, cross-sectoral collaborators, trainees, and investigators from other fields, locally, regionally, nationally, and internationally to promote new scientific collaborations, directions, and approaches.
2. Develop and support early-stage investigators to conduct research focused on improving diabetes prevention and treatment in health system and community settings through multi-modal, interdisciplinary research methods.
To this end, the MCDTR sponsors enrichment programming including the MCDTR Annual Symposium which brings together national and local experts in diabetes translational research to present and share research findings. The MCDTR also partners with the Institute for Healthcare Policy and Innovation (IHPI), the Michigan Institute for Clinical and Health Research (MICHR), the Caswell Diabetes Institute, Poverty Solutions, and Michigan Medicine Community Health Services to sponsor a seminar series focused on novel approaches for the prevention and treatment of diabetes. The seminar series will provide an opportunity for investigators, cross-sectoral collaborators, and trainees to present their research ideas, build community, and receive feedback from MCDTR core directors. In order to develop and support early-stage investigators, and ultimately build a pipeline of diabetes translational researchers, the MCDTR will provide a dedicated seminar/workshop series for individuals who are preparing K and R applications focused on diabetes translational efforts.
The seminar series will be focused on three intersecting fields of inquiry used to promote diabetes translational research:
1. Complex interventions at multiple levels of scale,
2. Social and behavioral determinants of health,
3. Dissemination and implementation science.
Participants will share and receive feedback on their drafts.